A Comprehensive Resource for Manipulating and Characterizing the Drosophila Genome

PROJECT SUMMARY
The Drosophila Gene Disruption Project (GDP), since its inception, has produced a large, publicly available
library of individual, sequence-mapped transposable element (TE) insertions that have become an
essential resource for fly research. More than 1,000,000 GDP fly cultures have been distributed to
thousands of labs nationally and internationally, facilitating the analysis of thousands of genes. Recently,
the GDP has pivoted to CRISPR mediated homologous recombination-based strategies to integrate
CRIMIC (CRISPR-mediated integration cassette) T2AGAL4 and KozakGAL4 cassettes in the coding region
of the targeted genes. These reagents provide unrivaled utility to facilitate functional annotation of genes,
greatly advancing the field of functional genomics. With the support of ORIP, we have targeted about 1400
genes in the last three years and we are on target to generate all the reagents we proposed to generate
with the previous grant support. In our renewal application, we propose to target an additional 2,000 genes
that have human homologs and have not been targeted so far. This will help the GDP towards reaching the
mission statement of generating versatile genetic reagents for most genes that are conserved between flies
and humans (currently about 3,500 of 9,500 genes). We also propose to conduct a more detailed
expression pattern analysis to document whole larvae expression patterns of the targeted genes by
combining state of the art tissue clearing methods and automated image acquisition. We will also document
the brain expression patterns in more detail in the third instar larval and adult brain and determine whether
the targeted genes are expressed in glia or neurons by conducting co-staining with glial and neuronal
marker genes. We note that the current single sequencing data lack the expression of genes that are
expressed at low levels and that our GAL4 technologies are extremely sensitive and have led to many new
biological findings. Finally, we propose to develop an enhancer-Flp transgenic stock collection that will
allow reversal of CRIMIC-T2AGAL4 alleles in a tissue specific manner to assess whether the role of the
gene in those cells is relevant for the observed phenotypes. We have already shown that this is a very
valuable and robust approach as it allows us to assess the role of specific cells with a simple cross and it
does not lead to overexpression or misexpression of the targeted gene. This collection will not only help in
depth analysis of CRIMIC alleles but also will help many other genetic tools developed by us and other
laboratories that employ Flp. The generation and distribution of these reagents is highly appreciated by the
Drosophila community as shown by the many letters of support from leaders in the fly community.

Public health relevance
PROJECT NARRATIVE The project will generate genetic reagents that will allow functional studies of 2,000 genes and widen the the breadth of experiments that can be conducted using new and existing reagents. We also propose a streamlined in-depth characterization of the expression pattern of all the targeted genes. These reagents and data often lay the foundation of new hypothesis driven research and support approaches that use fruitfly in a human genetics centered approach by allowing functional replacement of fly genes with human orthologs and their disease associated variants.